Defining the Immunogenicity and Efficacy of a Durable BCG Vaccine Strategy Optimized for Preventing TB in Pediatric HIV Infection

PROJECT SUMMARY
Tuberculosis (TB), caused by Mycobacterium tuberculosis (Mtb) remains a major cause of morbidity and
mortality worldwide and HIV+ individuals are particularly susceptible. The only licensed TB vaccine is the live
attenuated Bacillus Calmette-Guerin (BCG) that is given intradermally to infants. While BCG provides substantial
protection against non-pulmonary TB in childhood, it has little impact on pulmonary TB rates in adults. Recent
studies in macaques have elicited striking protection from TB by instead delivering BCG intravenously or
mucosally. However, BCG can cause disease in immunosuppressed recipients, including HIV+ children.
Recently, a more attenuated BCG strain, BCG𝚫1419c, has been shown to be safe in athymic mice,
immunogenic in both mice and guinea pigs, and more efficacious than BCG in both murine and guinea pigs
models of TB. In this proposal, we will use our pediatric Mauritian cynomolgus macaque (MCM) model of TB to
test both BCG and BCG𝚫1419c when given by the more clinically translatable mucosal route. Using MCM 1-2
years of age more closely resembles the pediatric population currently targeted for BCG vaccination. We will
characterize the immunogenicity of BCG and BCG𝚫1419c in these young MCM using a suite of powerful assays,
including multiparameter flow cytometry, single cell RNAseq, serology, and epigenetic analysis. We will
determine the protective efficacy of these vaccines by challenging the animals with virulent Mtb and then
assessing protection using our well-established and quantitative PET/CT imaging, pathology, and Mtb burden
measures. In Aim 2, we will use a similar approach to define the safety, immunogenicity and protective efficacy
of both BCG and BCG𝚫1419c in SIV+ juvenile MCM, modeling HIV+ children who could most benefit from an
improved TB vaccine.
We will test our hypothesis that this more attenuated BCG𝚫1419c will be safe, immunogenic, and protect from
Mtb when administered mucosally to juvenile MCM with and without pre-existing SIV infection. This multi-PI
proposal assembles a team of three established scientists with complimentary expertise in the fields of TB, HIV
and SIV, immunology, and pediatric infectious diseases. Furthermore, we already have an established
productive and collaborative relationship, ensuring successful completion of this important project.

Public health relevance
PROJECT NARRATIVE Tuberculosis (TB) is a major global health threat, especially for people living with HIV and BCG, the current TB vaccine, typically provides only poor protection. Here, we will use a macaque model of TB, both with and without an SIV infection, to explore vaccination with BCG, as well as the more attenuated BCG? 1419c, delivered to the respiratory mucosa rather than the standard intradermal route. Both TB vaccines will be assessed for safety, immunogenicity, and protective efficacy to guide the development of a safer, more efficacious, TB vaccine.